Administrative Core

The overarching goal of the Administrative Core of the Northwestern University (NU) Core Center for Clinical
Research (CCCR) is to support and organize our team of teams, i.e., the network that represents our CCCR,
and to optimize Center function and outcomes. This Core is responsible not only for CCCR management and
operations, but also for specific CCCR missions. For organized and dedicated efforts to achieve these
missions, we propose 3 Working Groups: the Mentoring Working Group will take charge of scientific and career
development of mentees, mentor development, and team cohesion; the Outreach, Dissemination, and
Enrichment (ODE) Working Group will take charge of communication, ODE activities, and expanding the
Research Community and fields of work; the Evaluation Working Group will be responsible for ongoing quality
and productivity assessment of CCCR activities, leveraging excellence in this area within NUCATS (NU
Clinical and Translational Sciences Institute, NU's CTSA). We will integrate the activities of the Community
Advisory Board (CAB) and Methodologic and Resource Cores. Steering, Oversight, and External Advisory
Committees will provide advisory support. These committees will include members with expertise in relevant
diseases and conditions, methodologies, and in management of core facilities. Administrative Core aims are:
1) provide the CCCR structure tailored to a) our vision of community engagement, interdisciplinary science,
and methodologies best supporting clinical research, and b) Core/CAB workflow to ensure their integration and
synergy; 2) provide a structure that will sustain effective and efficient CCCR operations; 3) provide expertise
and leadership to identify important projects and harness the CCCR to help them, maintaining highest rigor; 4)
promote cross-Core/CAB and Core/CAB-Research Community interactions to foster interdisciplinary work and
knowledge advancement; 5) optimize communication, cooperation, and collaboration among stakeholders,
CCCR investigators, and scientists at NU and elsewhere; 6) foster training and development of researchers,
and support development of applications for independent funding; 7) foster innovative and high-impact
exploratory projects within a Pilot and Feasibility program; 8) expand CCCR influence and contributions to our
environment by disseminating opportunities to use the Cores: 9) disseminate knowledge, empowering our
Research Community, the scientific community, Chicagoland communities, and the community at large; 10)
evaluate to a) help ensure that each Core is at the forefront to best position it to contribute to innovation, and b)
assess outcomes of our CCCR's work prospectively, using a priori designated metrics that incorporate team
science instruments; 11) lead an initiative including surveys and a workshop collaborating with the other
CCCRs and stakeholders, with the goal of better defining, capturing, and communicating the meaningful
impacts of the work that is enabled by the CCCRs; 12) ensure that a data and resource sharing plan is
implemented by each component of the CCCR.